Bayesian Variable Selection Methods to Accelerate Identification of Important Psychological Predictors and Neural Substrates of Psychopathology

Project Summary
NIMH seeks to “identify biomarkers and behavioral indicators with high predictive value, as early in the course
of illness development as possible”, in order to reduce the overall burden of mental illness. However, the
number of potentially important psychological, environmental, and biological factors of mental health disorders
is vast, and a key challenge is to narrow down to the most important predictors of disorder. This challenge is
made especially difficult as 1) recent advances in neuroscience begin to reveal neural substrates of
psychopathology, and 2) many predictors are themselves correlated, making it difficult to disentangle which
factors are reliably related to disease, after controlling for other factors. Currently used statistical methods are
inadequate to overcome this challenge. Powerful Bayesian variable selection methods, called stochastic
search variable selection (SSVS), can be used to identify predictors with the most robust relationships for a
given criterion, however these methods have not been developed for use in psychology and are currently only
available to specialized statisticians. The goal of this project is to develop guidelines to enable mental health
researchers to use SSVS to overcome current methodological barriers. I will also develop user-friendly online
applications to make SSVS easily available. For the first Aim of this study I will use computer simulation
studies to evaluate how SSVS works across a range of conditions and develop guidelines and software for
researchers to use. In the second Aim of this study I will apply SSVS to predict obsessive compulsive disorder
(OCD) symptoms in the Nathan Kline Institute Rockland sample, which is a large, publicly available database.
OCD is a common, chronic, and debilitating disorder. Much regarding risk for OCD remains unknown, which
limits efforts aimed at treatment and prevention. Previous research to identify potential risk factors and triggers
for illness onset has relied heavily on evaluation of individuals long after symptoms began. The predictors in
this sample include a wide range of theoretically-derived risk factors, including measures of potential
psychological vulnerabilities, brain connectivity, stressful life events, and key comorbidities. This proposed
research is embedded in a training and mentoring plan that will provide training in 1) the etiology and
assessment of psychopathology, 2) neuroscience approaches to determine neural substrates of
psychopathology, and 3) Bayesian variable selection methods. This K01 mentored research award will provide
the training, time and resources for me to make substantial advances towards addressing this important
problem and establish myself as an independent, R01-funded investigator.

Public health relevance
Project Narrative There is an urgent need for powerful and effective statistical tools to determine the most important risk factors of mental illness, especially as the list of potential risk factors grows. The proposed research will develop guidelines and freely-available online applications to allow researchers to use novel Bayesian variable selection methods to overcome current challenges to reliably predict mental illness. These methods are then applied to understand important predictors of Obsessive Compulsive Disorder symptoms in a large sample of adults across the lifespan. The findings of this research can inform efforts to identify and intervene to help at risk individuals to ultimately reduce the burden of mental illness.